Biodegradable Radiopaque Polymeric Scaffolds Loaded with Mesenchymal Stem Cells for Image-Guided Arteriovenous Fistula Maturation and Long-Term Patency

PROJECT SUMMARY/ABSTRACT
Complications associated with vascular access for hemodialysis represent one of the most important sources of
morbidity among patients with end-stage renal disease (ESRD) in the United States today. Among the various
types of vascular access, arteriovenous fistula (AVF) is preferred because it has better patency rates and fewer
complications than other access types. However, AVF primary failure impeding AVF maturation remains a
common problem and adding to patients’ morbidity and mortality. Neointimal hyperplasia (NIH) has been
identified as one of the main pathophysiologic culprits underlying AVF failure. Thus, improving AVF maturation,
reducing NIH, and optimizing imaging for accurate diagnosis and localization of NIH lesions are critical, as well
as understanding the mechanism of failure, so that therapeutic interventions can be executed.
Based on our preliminary data, we propose to develop novel, resorbable polymeric scaffolds with varying
physico-chemical properties that can be wrapped around the AVF to offer structural support and that can be
loaded with multifunctional, photoacoustic (PA)- and computed tomography (CT)-active nanoparticles (to
facilitate imaging) and mesenchymal stem cells (MSCs) (to mitigate inflammation and NIH). We will then test
their safety and efficacy in vitro and in vivo using a uremic rat and pig animal models. In addition, we will assess
the use of ultrasound (US) and PA imaging, in combination with positron emission tomography (PET) imaging
techniques for monitoring inflammation and AVF maturation. We hypothesize that this therapeutic strategy once
delivered locally and in a sustained manner, will increase the concentration in the AVF without systemic toxicity,
as well as provide structural support to enhance outward remodeling. We will test this hypothesis in three specific
aims: 1) develop a biodegradable polymeric scaffold containing nanoparticles and MSCs to mitigate inflammation
and subsequent pathologic NIH during AVF maturation, 2) assess various imaging techniques for monitoring
AVF maturation and integrity, and 3) assess physiologic, radiologic, and pathologic changes following
implantation of the engineered polymer in the peri-adventitial tissue surrounding iatrogenic AVFs in rat and pig
models.
The proposed work is significant and innovative because the step-by-step optimization of the physico-chemical
properties of the polymeric scaffold will improve the structure of the AVF, as well as delivery and retention of
MSCs, which would yield improved rates of AVF maturation and patency among ESRD patients on hemodialysis.
The successful completion of the proposed work will help us understand the mechanism of the pathogenesis of
non-maturing AVFs and whether polymeric scaffolds loaded with MSCs can modulate NIH. Furthermore, the
development of combined US/PA and PET/CT imaging will elucidate the role of not only inflammation but also
other targets in AVF maturation/non-maturation for potential drug and/or device development.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it is aimed at improving rates of arteriovenous fistula (AVF) maturation and long-term patency for patients with end-stage renal disease requiring hemodialysis. This study supports our long term-goal of understanding the mechanism in the pathogenesis of non-maturing AVFs and develop absorbable, imaging-capable medical devices that could modulate neointimal hyperplasia. Furthermore, development of an imaging technique based on combined ultrasound/photoacoustic (US/PA) and positron emission tomography (PET) imaging will assist with AVF monitoring and lead to an improved understanding of AVF maturation/non-maturation with potential for the development of novel therapeutic interventions.